The role of AIM2 in T cell-mediated autoimmunity

SUMMARY/ABSTRACT
T cell-­mediated autoimmune diseases such as Type 1 diabetes (T1D) are due to complex events leading to
dysregulation of central and peripheral tolerance. Defining the mechanisms regulating self-­tolerance are critical
for understanding the autoimmune process as well as for rational development of immunotherapies to prevent
and treat T1D and other T cell-­mediated autoimmune diseases.

This application is based on our novel observation that NOD mice deficient in the AIM2 inflammasome
molecule remain diabetes-­free. AIM2 is a cytoplasmic immune sensor involved in host defense. Upon binding
double stranded DNA from a microbial pathogen, AIM2 assembles into an inflammasome complex that drives
the production of proinflammatory IL-­1bβ and IL-­18, and pyroptosis-­mediated cell death. Recent studies,
however, have demonstrated that AIM2 can serve a regulatory function outside of host defense via a
nonconical pathway that is independent of inflammasome activation. Here, AIM2 functions as a negative
regulator of the kinase DNA-­PK in the PI3K/AKT signaling pathway.

We find that the lack of diabetes in AIM2-­deficient NOD mice is also independent of inflammasome activation.
Furthermore, evidence suggests that bβ cell autoimmunity in AIM2-­deficient NOD mice is blocked by multiple
mechanisms affecting thymic antigen presenting cells, peripheral dendritic cell function and T cell subset
differentiation. We hypothesize that AIM2 serves as a key checkpoint in regulating PI3K/DNA-­PK/AKT-­
dependent stimuli and cellular maturation/differentiation, which impacts self-­tolerance and the diabetogenic
response. Our goal is to define the key mechanisms by which AIM2 regulates self-­tolerance. With this in mind,
Specific Aim 1 will focus on AIM2 effects on the stimulatory function of medullary thymic epithelial cells and
thymic dendritic cells. Specific Aim 2 will define the role of AIM2 in regulating dendritic cell proinflammatory
versus tolerogenic function. Finally, Specific Aim 3 will investigate how AIM2 controls the efficiency of
pathogenic T cell subset differentiation. This work is expected to provide insight into new mechanisms and
pathways by which central and peripheral self-­tolerance are regulated, as well as a foundation to target the
AIM2 pathway for therapeutic purposes.

Public health relevance
NARRATIVE The goal of this work is to define the role of the AIM2 inflammasome molecule in regulating T cell self-tolerance in the context of type 1 diabetes. The proposal will establish new pathways that control thymic and peripheral antigen presenting cells, and peripheral T cells. Targeting these AIM2-dependent pathways may also provide a strategy to enhance the efficacy of T cell- and dendritic cell-based immunotherapies.